The role of GPR133 in glioblastoma

PROJECT SUMMARY/ABSTRACT
Glioblastoma (GBM) is a deadly primary brain malignancy with limited therapeutic options. Tumor
progression is thought to be driven by stem cell-­like cells that evade conventional chemoradiotherapy and anti-­
angiogenic treatment. Indeed, anti-­angiogenic therapy and subsequent worsening of tumor oxygenation promote
hypoxia-­resistant stem cell phenotypes that lead to further tumor progression. However, our understanding of
mechanisms that underlie both GBM stem cell (GSC) behavior and its regulation by oxygen tension remains
incomplete. In our effort to identify novel targetable mediators of the GSC phenotype, we recently discovered that
GPR133 (ADGRD1), an orphan member of the adhesion family of G protein-­coupled receptors, is necessary for
initiating tumor growth in vitro and in vivo, both GSC properties, in part by triggering signaling mechanisms that
increase cytoplasmic cAMP and lead to transcription of genes necessary for “stemness”. While GPR133 is
absent from normal brain tissue, it is expressed with full penetrance in all GBM specimens tested, regardless of
molecular subtype. On the basis of these findings, we hypothesize that GPR133 is a critical component of tumor
growth by supporting the GSC phenotype. We, therefore, believe that GPR133 inhibition represents a novel and
appealing therapeutic strategy in GBM that merits further testing and development.
We now seek to expand on our published findings and use patient-­derived GBM models to elucidate basic
mechanisms of action of GPR133. Aim 1 will test the hypotheses that GPR133 identifies GBM stem cells and its
knockdown in tumor xenografts slows tumor growth and prolongs survival. Aim 2 will build on our finding that,
within each tumor, GPR133 expression is highest in the most hypoxic regions, suggesting regulation by oxygen
tension. More specifically, we will determine the effect of intratumoral fluctuations in oxygenation on GPR133
expression by correlating mRNA and protein levels with tumor vascularity and oxygenation using targeted
intraoperative biopsies of patient tumors. In addition, Aim 2 will determine whether GPR133 knockdown
synergizes with cediranib, an anti-­angiogenic agent, to prevent tumor progression after aggravation of tumor
hypoxia. Finally, Aim 3 will determine the relative contribution of canonical G protein signaling initiated by
GPR133 and transduced by cAMP and its effectors RAP and PKA, and adhesion mediated by GPR133’s long N-­
terminal ectodomain, to the transcriptional regulation of genes that support the GSC phenotype.
The proposed studies will mechanistically clarify GPR133’s role in tumor progression, including in hypoxia
exacerbated by anti-­angiogenic therapy. The results of these studies will complement our ongoing small
molecule inhibitor and physiological ligand discovery efforts. We envision GPR133 inhibition as a testable novel
approach in GBM, either by itself or as a powerful “one-­two punch” when combined with anti-­angiogenic therapy,
that can target both hypoxia-­vulnerable and hypoxia-­resistant tumor cells.

Public health relevance
PROJECT NARRATIVE We recently discovered that GPR133, a cell surface receptor, is critical for growth of glioblastoma, a deadly brain malignancy. The proposed study will determine cellular and molecular mechanisms that GPR133 utilizes to promote tumor progression. We envision GPR133 inhibition as a novel therapeutic alternative against this otherwise refractory cancer.